Institutional Career Development Core

Contact PD/PI: Dubinett, Steven M. Inst-Career-Dev-001 (671)
I. INSTITUTIONAL CAREER DEVELOPMENT CORE
SUMMARY/ABSTRACT
The proposed UCLA CTSI KL2 grant builds upon long-standing relationships among our CTSI institution partners
– UCLA, Cedars-Sinai, Harbor-UCLA/Lundquist and Charles R. Drew University – of jointly training translational
scientists. Since our last renewal in 2016, we have greatly expanded our programs to include initiation of our K
Scholars Society, longitudinal grant writing studios, development of a platform for sharing successful grants, and
training in team science, communication and mentorship. 100% of graduates have remained in research careers,
83% have received subsequent extramural funding as PI, and our 45 scholars have published 733 peer-reviewed
articles. Our scholars are diverse; 53% are women and 15% are from under-represented minority or
disadvantaged backgrounds. We now propose to build upon these successes with the following objectives: 1)
Enhance and expand career development support and translational science training resources, 2)
Leverage institutional support and matching funds to expand the KL2 Program for additional
institutional K scholars, 3) Create a supportive environment for young investigators that fosters a culture
of exploration, collaboration, leadership, mentorship and entrepreneurship, 4) Improve the recruitment,
career development support, mentoring programs, and funding support for women and minority faculty,
and 5) Provide, monitor and continuously improve the structured oversight of educational and training
needs for all UCLA CTSI KL2 Scholars. The KL2 Program will select three junior faculty (e.g., assistant
professor) per year and provide three years of support at 75% effort. With institutional funds, we will supplement
the program with additional institutional career development awards for highly qualified junior faculty. The KL2
Program is actively committed to achieving equity and diversity with the long-term goal of a research workforce
that is representative of the general population. In the near term, we will continue to actively recruit and support
diverse faculty with the goal of maintaining 50% women and reaching 25% from URM/disadvantaged
backgrounds. Key outcomes for the KL2 Program will be the success rate of KL2 Scholars in obtaining grants,
number of peer-reviewed publications in high-impact journals, scientific impact using novel metrics, and impact
on the health of patients and the community in Los Angeles, nationally and worldwide.
Frequently used abbreviations. CREST, Clinical Research Education and Specialized Training; IDP,
Individual Development Plan; NCSP, National Clinicians Scholars Program; PDSA, Plan, Do, Study, Act;
RAP, Research Associates Program; RCMAR, Resource Centers for Minority Aging Research; TPTS,
Training Program in Translational Science; TS, Team Science Program; UHI, Urban Health Institute; URM, underrepresented minority; WDP, Workforce Development Program